IL-17 receptor signaling in megakaryocytes and the implications for oral mucosal immune responses during oropharyngeal candidiasis

The role of megakaryocytes (megs) in oral- and craniofacial-related diseases is almost entirely unknown.
Recent studies established that megs have immune functions unrelated to platelet biogenesis. While megs are
normally found in the bone marrow, populations have been detected in the lungs and we have now found them
in the oral cavity. The goal of this project is to investigate the how megs in the oral mucosa respond to cytokine
signals during health and oropharyngeal candidiasis (OPC) caused by Candida albicans. Oral meg populations
expand during OPC, and this expansion requires the proinflammatory cytokine interleukin-17 (IL-17), but how
the cytokine influences the process of megakaryopoiesis in the oral cavity is unknown. IL-17 is a central
immune hub in the oral mucosa and critical for protection during OPC. The long-term goal is to elucidate the
role of IL-17 receptor (IL-17R, subunits RA and RC) signaling in megs which would establish a new paradigm
form IL-17 signaling in hematopoietic cells in mediating protection against OPC. This is a critical to understand
since OPC infections are a major complication for the immunocompromised including cancer and HIV+
patients. The overall objective of is to determine how megs contribute to IL-17R-mediated oral mucosal
immune responses. The central hypothesis is that is that IL-17R signaling specifically in megs is
immunologically relevant during OPC. This hypothesis is based in part on preliminary data produced in the PI’s
laboratory. The rationale that underlies the proposed study is that once it is known how megs participate in oral
mucosal immunity, therapeutics involving megs can be developed to effectively treat Candida infections and
vascular diseases. This hypothesis will be tested in the following Aims: 1A) To assess the responses of human
meg cell line (MEG-01) to IL-17; 1B) To determine the components important in signaling downstream of the
IL-17R in MEG-01 cells. RNA-Seq and qPCR analysis will elucidate the genes expressed when cells are
stimulated with IL-17 alone or in combination with other agonists. We will assess signaling components
downstream of IL-17R through siRNA knockdown. In Aim 2A and B we will define meg-specific IL-17RA
signaling during OPC by crossing platelet-factor 4-Cre recombinase mice (PF4-Cre; expressed by megs) with
Il17rafl/fl mice. We will expand our studies to also focus on the noncanonical NF-kB transcription factor Ikbz
(encoded by Nfkbiz) which is activated by IL-17. To understand the role of IkBz in megs, we will target the
Nfkbiz gene selectively in megs using the PF4-Cre mice crossed with the Nfkbizfl/fl mice. We hypothesize that
IL-17RA through activation of IkBz contributes to immune responses specifically mediated by megs during
OPC, and mice deficient in these signaling components will be susceptible to OPC. Understanding the
immune functions of oral megs will have a transforming effect on the field of meg/platelet biology and oral
mucosal immunity. This proposal opens the potential for the oral health field to reevaluate the contribution of
megs in other oral inflammatory conditions that IL-17R signaling is using the tools we will generate.

Public health relevance
PROJECT NARRATIVE The oral epithelium is an important part of immunity against infection, but the cell populations involved, including megakaryocytes, are not well understood. The proposed research is relevant to public health because fungal infections caused by the commensal fungus Candida albicans are serious in patients with immune system defects. This proposal will study the role of megakaryocytes as oral immune cells so we can better understand these cells during health and disease.